Mechanisms of human adipose tissue development and impact of diabetes

ABSTRACT
The distribution of adipose tissue among central and lower body depots is a major predictor of Type 2 Diabetes
(T2D) and cardio metabolic disease risk. However, the mechanisms that control regional adipose tissue
development, and how each depot diﬀerentially impacts systemic metabolism, are not well understood. The
goal of this proposal is to elucidate these mechanisms by leveraging powerful new approaches to generate
functional adipose tissue in mice from mesenchymal progenitor cells derived from human adipose tissue.
During the past budget period, we obtained and characterized progenitor cells from the abdominal (ABD) and
gluteo-femoral (GLU) depots from individuals with normal glucose tolerance (NGT) or with T2D. We now seek
to use these cells to elucidate mechanisms by which these adipose depots develop, selectively impact systemic
metabolism, and inﬂuence T2D pathogenesis. We propose the following speciﬁc aims: Aim 1. We will test the
hypothesis that functionally distinct adipose depots will be generated from progenitor cells from ABD or
GLU depots from subjects with NGT or T2D, and that these depots will diﬀerentially impact systemic
metabolic homeostasis in the mouse host. These “human” adipose depots will be generated in two mouse
models of insulin resistance: ﬁrst, in the well-characterized NSG mouse on a high-fat diet, and second, in a newly
developed model lacking endogenous adipose tissue due to knockout of the BSCL2 lipodystrophy gene, in
which all functional adipocytes will be from human origin. This will provide exceptional sensitivity to detect
the selective eﬀects of each depot on mouse metabolic parameters. Aim 2. In vitro, progenitor cells from subjects
with T2D display an impaired commitment to the adipogenic fate. We will test the hypothesis that this
impairment is due to enhanced WNT signaling, which in the prior budget period we have found to be a
critical determinant of mesenchymal progenitor adipogenic diﬀerentiation. We will measure WNT signaling
directly and compare the developmental trajectory of progenitor cells from NGT and T2D subjects using newly
discovered markers for each developmental fate. Aim 3. We will deﬁne the speciﬁc WNT ligands operating
across the human adipocyte diﬀerentiation trajectory, and their impact on the development and function of
adipose tissue in vivo. Using CRISPR-Cas9, we will selectively knockout each of the WNT ligands expressed at
distinct points during human adipocyte diﬀerentiation from progenitor cells and assess the impact on tissue
development in-vivo. Deﬁning the role of the WNT pathway in human adipose tissue development will help
understand the basis for the strong genetic association between T2D risk and polymorphisms in TCF7L2, a
critical element of the WNT pathway. It will also provide a framework to explore targeting of adipose tissue
WNT ligands as a potential therapeutic strategy in T2D.

Public health relevance
NARRATIVE Obesity increases the risk of diseases such as Type 2 Diabetes (T2D), fatty liver and heart disease. However, adipose tissue plays many beneficial functions, and healthy adipose tissue formed in the lower part of the body can actually protect from metabolic diseases. Our research will reveal the differences between upper body and lower body adipose tissue, and how lower adipose tissue protect from T2D.